Long-acting injectable tacrolimus for chronic immunosuppression

PROJECT SUMMARY
The broad, long-term goal of this Direct to Phase II SBIR is to improve immunosuppression outcomes in organ
transplant recipients by developing a long-acting injectable calcineurin inhibitor (CNI). For more than two
decades, tacrolimus is a valuable pharmacological tool in the prophylaxis of organ transplant rejection. It is
commercially available as twice and once-daily oral pills. Oral formulations undergo first-pass metabolism and
suffer from low and variable bioavailability which in turn leads to high intra- and inter- patient pharmacokinetic
(PK) variability. Tacrolimus has a narrow therapeutic index, hence sub-therapeutic blood levels (<5 ng/ml)
results in organ rejection whereas supra-therapeutic levels (>15 ng/ml) are toxic. Daily dosing has been
associated with medication non-adherence. The medical costs transplant recipients with poor adherence are
~$30,000 higher than patients with high adherence at 3 years post-transplant. Thus, the three reported unmet
needs are higher medication adherence, better outcomes of graft survival, and linear PK profile.
Auritec Pharmaceuticals has developed a subcutaneous injectable formulation of tacrolimus that provides
consistent therapeutic blood levels of the drug for 30 days after a single administration. The product is based
on Auritec’s innovative Plexis technology that has shown clinical proof of concept in two Phase 1 trials. The
Plexis technology is differentiated from other long-acting injectable technologies in terms of its high drug
loading, scalable manufacturing process, and more linear release kinetics. The product has demonstrated safe
and sustained release of tacrolimus in a first-in-human safety/PK study using the “exploratory IND” approach.
PK modeling shows that a monthly dosing schedule can be readily achieved in transplant recipients to maintain
tacrolimus blood levels in the safe and efficacious range (5-15 ng/ml). The benefits of our product include 1)
complete medication adherence for 1 month after one administration; 2) fewer episodes of graft rejections; 3)
simpler dosing schedule, and; 4) a smooth PK profile without sub- or supra-therapeutic levels. The populations
anticipated to benefit from the product are: Patients who have demonstrated tolerability to tacrolimus but find it
challenging to adhere to a daily fixed schedule (such as younger patients) and/or rapid metabolizers of
tacrolimus. The end result will be a cost-effective maintenance therapy for maintenance therapy.
The specific aims of this Direct to Phase II SBIR are to perform activities in pursuit of a “traditional Phase 1
IND” allowance. The proposed work includes - manufacturing in accordance with current Good Manufacturing
Practices (cGMP); animal testing in compliance with Good Laboratory Practices (GLP); analytical method
development; Chemistry, Manufacturing and Controls (CMC) testing; and finally, IND submission to the FDA.
These efforts will result in an IND approval and allow for the first-in-human testing of safety, PK, and
preliminary efficacy in transplant recipients. Successful completion of this work will further de-risk the product
by bringing it closer to clinical testing and making it attractive to investors.

Public health relevance
PROJECT NARRATIVE Hundreds of thousands of patients depend on tacrolimus-based immunosuppression for the survival of their donated organs, which commonly develops after the transplantation procedure. Currently available oral tacrolimus formulations require daily dosing, and their variable drug release results in sub-therapeutic efficacy and toxicity-inducing peaks, which leads to poor healthcare outcomes. To address this important issue, we have developed a monthly injectable formulation of tacrolimus which will release in a linear manner and result in superior safety and effectiveness.